Cardiovascular Research Training Program

Abstract
This is the fourth competitive renewal of the University of Washington Cardiovascular Research Training
Program. This application requests support for a Program that provides structured multidisciplinary research
training to 5 MD, PhD, or MD/PhD trainees per year. The Program builds on a strong tradition of
cardiovascular research and clinical training at the University of Washington School of Medicine. Training
opportunities are provided in five broad areas: 1. Signaling and Vascular Injury. 2. Molecular and Cellular
Therapies. 3. Bioengineering/Biomechanics/Imaging. 4. Genetics and Genomics of Cardiovascular Risk. 5.
Cardiovascular Population Science. The Program supports research training with faculty who hold primary
appointments in 11 distinct academic departments in the School of Medicine and School of Public Health. The
faculty is highly collaborative as evidenced by joint publications, co-mentoring of trainees, and participation in
Program Projects and Center grants. The faculty also has a long track record of successful mentoring and
support of trainees. Several early trainees of this Program now hold senior academic positions around the
country. Training supported by this Program includes mentored research experience under the primary
direction of our Program faculty and group activities such as didactic courses and seminars. Each of our
trainees has a tailored training plan that is designed to promote early success, to broaden scientific knowledge
and expertise, and to enhance essential career skills. The Program is the major source of support for clinical
fellows in Cardiology and residents in Surgery who wish to acquire skills necessary to become independent
principal investigators in cardiovascular research. The Program is also a critical source of support for trainees
with PhD degrees who wish to pursue training in either basic or population-oriented cardiovascular science.

Public health relevance
Project Narrative The goal of this T32 program is to train independent investigators for careers in cardiovascular research focusing on either basic science or population science. This program supports full-time research training for individuals with doctoral degrees (MD, PhD, or both). Research training is provided in several areas including: identifying the causes of cardiovascular diseases; and improving our ability to diagnose, treat, and prevent cardiovascular diseases.